Cardiovascular Development Data Resource Center (CDDRC)

PROJECT SUMMARY
Congenital heart disease (CHD) affects approximately 1% of all children born per year in the United States.
The NHLBI has made significant investments to discover the causes and outcomes of CHD, including research
in the Bench-to-Bassinet (B2B) Consortia that spans fundamental discovery science in the Cardiovascular
Development Consortium (CvDC), sequencing the genomes of clinically phenotyped children with CHD and
their parents in the Pediatric Cardiac Genomics Consortium (PCGC), and long-term clinical follow-up and
outcomes research in the Pediatric Heart Network (PHN). The advent of Next Generation Sequencing (NGS)
has rapidly accelerated discoveries in cardiovascular development and the genetics and epigenetics of CHD.
Both the CvDC and the PCGC have extensive NGS datasets. The CvDC DataHub at the University of Utah
currently serves as the programmatic data warehouse and distribution server that organizes NGS datasets and
makes them available online. CvDC datasets are complex, containing NGS experiments from seven ‘model
organism’ species (mice, zebrafish, humans, alligator, turtle, chicken, sheep and frogs) and humans.
Importantly, the experiments in the CvDC explore the molecular etiology of cardiovascular development
through several coordinated -omics approaches, studying changes in the whole-genome transcriptome and in
the epigenome (chromatin modifiers, transcription factors, the DNA methylome and higher-order organization
of chromatin) during cardiac development and in several mutant genetic backgrounds.
The Cardiovascular Development Data Resource Center (CDDRC) will be built on the innovative Mosaic
platform to provide a cloud-based collaborative space for organizing, visualizing and understanding genomic
data, and for pointing analytic tools to datasets housed anywhere on the cloud. The CDDRC is designed by
experts in computational sciences and bioinformatics, in consultation with leaders in the CvDC, PCGC and
PHN to be used by non-experts, basic scientists, human geneticists and clinicians. The University of Utah is
one of a few institutions in the country that has leadership in all three B2B consortia, reflecting the depth and
diversity of our expertise and our commitment to cross-disciplinary collaborations. The CDDRC will provide a
suite of cloud-compatible tools and a coordinated and a harmonized set of datasets transported from the
previous CvDC DataHub, imported from current CvDC projects, and recruited from the cardiovascular
development and pediatric CHD research communities. The CDDRC will facilitate dynamic and investigator-
interactive interfaces with multiple -omics datasets from humans and multiple model organisms, resulting in
collaborative discoveries of the genetic and epigenetic causes of CHD. In addition, our program will have
educational components in Ethical, Legal and Social Implications (ELSI) of CHD genetics and genomics, and
an outreach program in CHD computational biology for students from underrepresented groups.

Public health relevance
PROJECT NARRATIVE The Cardiovascular Development Data Resource Center (CDDRC) will provide an innovative cloud-based platform to facilitate the analysis, visualization and sharing of genomic data from research in heart development in several species. The CDDRC will bring together researchers with a diverse range of expertise, with the goal of understanding the causes of congenital heart disease in children.